Comparative Medical Science Training Program

A demonstrable need to train and retain veterinarian-scientists is outlined by several National Research Council reports (2004, 2005 and 2013) as well as by the National Institutes of Health Physician-Scientist Workforce Report (2014). In response, the mission of the Comparative Medical Scientist Training Program (CMSTP), is to prepare post-DVM PhD students to become exceptional veterinarian-scientists in comparative medicine at the University of California, Davis (UC Davis). This post-doctoral T32, currently in its 34th year, has been very successful in training veterinarian-scientists for research careers with >90% utilizing their research training. Specifically, 34 trainees have participated in the program with 9 in faculty positions, 4 in postdoctoral fellowships, 3 in government, 6 in industry, 9 completing their PhD (5 currently in CMSTP), 1 in a clinical residency and only 2 in non-research clinical positions over the past 15 years. To ensure the success of our new trainees, we propose a comprehensive 4-year CMSTP at UC Davis, which supports 8-9 DVMs/year to pursue their PhD. Institutional commitment provides 2 students/yr with a summer rotation program, in which they select a research mentor from 1 of our 36 faculty trainers before entering graduate school. In the first year, students take classes and prepare for their PhD qualifying exam. Successful students would then receive 1 of 6 three-year T32 fellowships to support their laboratory research in years 2-4 of their graduate career; the School of Veterinary Medicine (SVM) will support one additional training slot. We will prepare trainees for the next stage of their careers through provision of research colloquia, individualized mentoring, networking opportunities, and grant writing workshops. Thus, CMSTP provides a comprehensive, integrated research-mentoring program for DVMs at UC Davis to remove barriers that exist and deter some from pursuing a research career. The CMSTP takes advantage of outstanding research and teaching opportunities in the biological sciences at UC Davis by bringing together faculty from the SVM, the nation’s top veterinary school, the School of Medicine, the College of Engineering, and the College of Biological Sciences. Most of our training faculty participate in established Centers and Institutes that promote collaborations and employ evidence-based approaches to solving scientific problems through state-of- the-art equipment in individual labs as well as campus shared facilities. The objectives of the CMSFP are to: 1) prepare all of our trainees to become future leaders in academia, government service, public health, and biomedical research, 2) provide greater exposure to career paths outside academia, 3) maintain the average time of 4 years to degree, and 4) attract and train an excellent group of veterinarian-scientists.

Public health relevance
PROJECT NARRATIVE Veterinarians are trained as comparative biologists with an understanding of all living species and ideally suited to solve the complex problems presented by current and future medicine in humans and animals. The goal of the UC Davis Comparative Medical Scientist T32 Training Program is to provide an outstanding environment in biomedical research training at the nation's top-ranked School of Veterinary Medicine and to prepare our students with DVM-PhD degrees to become compassionate and exceptional clinician-scientists engaged in basic and translational research to advance the health of people and animals, in the context of their changing environment. This program addresses a national shortage of research-trained veterinarians who will conduct independent research utilizing animal model systems of human diseases as well as steward appropriate care and use of laboratory animals.